Structural-Transcriptional Relationships that Improve Y537S Estrogen Receptor Antagonism

Summary
This proposal studies how drug-induced structural changes to Y537S estrogen receptor alpha (ERα) impact anti-
tumoral activities in hormone-resistant breast cancer cells. Breast cancer is the second leading cause of cancer
death in the United States. Acquired resistance to hormone therapies is a leading contributor to mortality. In
approximately 40% of progressive ER+ patients, prolonged selective pressure by antiestrogenic therapies gives
raise to tumors bearing activating somatic ESR1 (the gene for ERα) mutations. These mutations resist inhibition
by clinically approved hormone therapies and engage new transcriptional programs that boost metastatic
potential. Y537S missense mutation is among the most common and enables the greatest hormone-free
transcriptional activities and resistance to antiestrogen. Next generation selective estrogen receptor degraders
(SERDs) have been clinically deployed to address this mechanism of drug resistance. However, they show
variable activities in Y537S ESR1 breast cancers and possess common side-effects that will limit their long-term
use. We recently studied how a panel of 17 selective estrogen receptor modulators (SERMs) and SERDs bind
to and affect Y537S ERα activities in breast cancer cells. We identified structurally distinct SERMs and SERDs
with improved activities in this setting. While structurally distinct, our x-ray co-crystal structures showed that the
most effective molecules engaged the same S537-E380 hydrogen bond to reinforce the therapeutic antagonist
conformation. Therefore, we hypothesize that novel ligand-dependent structural interactions will improve
therapeutic antagonistic activities in the Y537S ESR1 setting. In this study, we will leverage our library of over
100 diverse SERMs and SERDs to reveal the structural-transcriptional relationships that underlie improved anti-
cancer activities Y537S ESR1 breast cancer cells. We will start by studying how our library binds to and affects
Y537S ERα structure and anti-cancer activities (Aim 1). This approach will reveal the ligand binding modes and
structural interactions that enable potency. Next, we will study how the most effective molecules impact Y537S
ERα genomic activities including protein-protein interactions, genome binding, and transcriptional programing
(Aim 2). This approach will show whether the efficacies of SERMs and SERDs arise from alterations to Y537S
ERα genomic activities. Finally, we will reveal the anti-tumor and tissue-specific activities of the most effective
SERMs and SERDs in hormone-resistant ER+ breast cancer in vivo (Aim 3). This approach will reveal whether
our in vitro observations correspond to improved anti-cancer activities in patient-relevant tumor models. Overall,
these studies will provide detailed structural-transcriptional relationships to improve therapeutic targeting of
Y537S ERα in hormone-resistant breast cancer.

Public health relevance
Project Narrative Activating somatic mutations to estrogen receptor alpha (ERα) enable hormone therapy resistance and significantly contribute to breast cancer mortality. We recently identified a novel therapeutic structural interaction that correlates with improved anti-cancer activities for Y537S ERα, the most aggressive and drug-resistant of the known mutants. We will use a library of over 100 structurally diverse ERα-targeted small molecule antagonists to reveal the interplay between Y537S ERα structure, genomic actions, and anti-cancer activities to overcome hormone therapy resistance in breast cancer.